Longitudinal Proteomic and Metabolomic Predictors of Pancreatic Cyst Malignant Progression and Early Stage Pancreatic Cancer

Project Summary/Abstract
Pancreatic ductal adenocarcinoma (PDAC) has a dire prognosis mainly due to its late diagnosis. It is vital to
identify early-stage PDAC and its precursors. One such precursor is intraductal papillary mucinous neoplasm
(IPMN), a type of pancreatic cyst. International consensus guidelines recommend resection of IPMN with high
malignancy risk and surveillance of IPMN without surgical indications. Based on radiologic/clinical findings, the
guidelines have a dismal specificity for discerning benign from malignant IPMN and a poor accuracy of
predicting IPMN malignant progression. It is urgent to identify biomarkers that predict malignant progression of
presumed “low-risk” IPMN. The primary objective of the proposed study is to identify and validate protein and
metabolite signatures and their longitudinal changes which can discriminate IPMN malignant progression and
detect early-stage PDAC. Supported by preliminary data, our central hypothesis is that the levels and
trajectories of such signatures in plasma and/or pancreatic cyst fluid are predictive of IPMN malignant
progression and early-stage PDAC. Specific Aims: 1. Investigate plasma and cyst fluid levels and trajectories
of proteomic biomarkers and metabolomics signatures for prediction of IPMN malignant progression in a
prospective surveillance cohort. 1A: A global proteomics and metabolomics study of pancreatic cyst fluid in
160 IPMN surgical patients will be conducted to identify proteins and metabolites associated with high-grade
and invasive IPMN. 1B: Top proteins identified from 1A and 6 proteins (THBS2, PGE2, LRG1, TIMP1, C1RL, &
PTPRJ) discovered in our preliminary studies will be measured in serial plasma (n=3) and cyst fluid (n=~2.5)
samples from 500 IPMN patients under surveillance. 1C: Top metabolites identified from 1A and 4 plasma
metabolites correlated with IPMN dysplasia grade in our R21 study will be quantified in the 1B population. The
levels and trajectories of proteins and metabolites measured in 1B and 1C will be evaluated in relation to IPMN
malignant progression. 1D: A risk prediction model for IPMN malignant progression will be built from proteins
and metabolites identified and validated in 1B and 1C, CA 19-9, and clinical/imaging features. 2. Evaluate
levels and trajectories of plasma proteomic biomarkers and metabolomics signatures for detection of early-
stage PDAC in a PRoBE-compliant case-control study nested in the PLCO cohort. 2A: proteins identified in 1A
and 6 biomarkers listed in 1B will be measured in serial prediagnostic plasma samples (n=up to 3) from 242
PDAC cases (incl. 80 early-stage cases) and 242 matched controls. 2B: In the 2A population, top metabolites
identified from 1A, 4 metabolites described in 1C, and 5 metabolites predicting early-stage PDAC in our pilot
studies will be determined. 2C: A risk prediction model for early-stage PDAC will be developed from proteins
and metabolites identified in 2A and 2B, CA 19-9, and clinical/imaging features. Our expected results will allow
clinicians to timely resect IPMNs with high malignant potential before progression to invasive cancer, while
avoiding unnecessary surgeries. Detecting early-stage PDAC will substantially increase patient survival.

Public health relevance
Public Health Relevance (Project Narrative) International consensus guidelines have a dismal specificity for discriminating benign from malignant intraductal papillary mucinous neoplasm (IPMN) (a type of common pancreatic cyst and precursor to pancreatic cancer) and a poor accuracy of predicting IPMN malignant progression during surveillance. The proposed study is expected to develop models that integrate plasma and pancreatic cyst fluid levels and trajectories of protein and metabolites with clinical and imaging features, which are more accurately predictive of IPMN malignant progression and early-stage pancreatic cancer than the current clinical guidelines based solely on clinical and imaging findings. Such expected results are significant because they will lead to an improved clinical management of IPMN and an increased long-term survival of pancreatic cancer patients.